Replication Fork Repair

PROJECT SUMMARY Replication fork repair is essential for cell survival and stability of genetic material. In humans, inefficiency of repair is associated with cancer proneness, neurological, immunological, developmental defects and premature aging. The long-term goal of this study is a more complete mechanistic understanding of the repair of replication gaps. The objective of this project will be to elucidate elements of replication gap repair pathways, including specific replisome components, using genetic and biochemical experiments. Because all cells repair DNA in fundamentally similar ways by evolutionarily related pathways, these studies using the model organism, Escherichia coli, should reveal mechanisms applicable to repair of DNA in human cells. The use of azidothymidine (AZT) in this study as a compound to induce replication gaps has the potential to reveal toxicity and tolerance mechanisms relevant to its therapeutical use as an anti-HIV agent. In addition, because the DNA damage response in bacterial pathogens plays a role in toxin production, antibiotic resistance and persistence of infection, this work could provide new targets for antibiotic therapy. The first aim of this proposal is to identify the mechanism by which RadA, a universal bacterial protein related to RecA, assists homologous recombination. In vitro, RadA stimulates RecA-mediated recombination reactions by accelerating branch migration of strand exchange intermediates. The mechanism of this stimulation will be deduced by biochemical and genetic experiments, to determine how RadA and RecA interact to promote recombination. The second aim of this study seeks to clarify how replisome clamp-loader complexes and repair proteins interact to facilitate repair. The YoaA protein, a member of the XPD/FANCJ family of helicases mutated in human disease syndromes, will be studied by genetic and biochemical methods to ascertain whether it is a DNA helicase, how this activity is specialized and how it promotes replication gap repair. Interactions with the replisome will be examined genetically and biochemically. The abundance, in vivo, of DnaX-variant clamp- loader complexes and their regulation will be determined, as well as their role in promoting genetic stability. A new method for isolation of proteins associated with AZT-terminated gaps will be developed to identify and assay recruitment of replication and repair proteins to sites of replication blockage. This study will significantly advance the field of DNA repair by providing new information regarding how replication gaps are sensed and repaired.

Public health relevance
Project Narrative We will study the mechanisms by which cells repair damage to DNA. This provides information about how cells may avoid genetic changes that lead to cancer or aging.